Safe harbor landing sites as community resource for next-generation transgenesis in zebrafish

PROJECT SUMMARY
Transgenesis to generate reporters or genetic modifiers is a key tool for biomedical research organisms.
Zebrafish are a critical model to study early vertebrate development, regeneration, and congenital disease,
with transgenic zebrafish as uniquely powerful tools to visualize and perturb biological processes. However,
routine generation of transgenic zebrafish using random genomic integration of linearized DNA vectors or Tol2
transposons remains a major challenge in the field: beyond highly variable transgene activity due to chromatin
position effects, the required number of animals, resources, and time to select high-quality, single-integration
transgenes remain prohibitive to numerous labs. Site-directed transgenesis into so-called safe-harbor landing
sites, genomic locations with faithful transgene activity, is critically missing in zebrafish.
In Drosophila and mouse, phiC31 integrase-mediated transgenesis of DNA vectors into engineered, carefully
selected attP landing sites has revolutionized the field. Access to several attP landing sites enable predictable,
reproducible, and economical transgene generation for numerous biomedical research applications, including
quantitative assessment of disease variant genes, predictable expression of genetic modifiers, and routine
generation of fluorescent reporters. Building on our pioneering work on phiC31 integrase transgenesis, we will
establish and expand community-accessible resources for site-directed transgenesis in zebrafish.
Replacing two previously established Tol2-based transgenes with attP sites through CRISPR-Cas9, we
generated the first possibly universal landing site strains for zebrafish as phiC31 Integrase Genomic Loci
Engineered for Transgenesis (pIGLET). We documented reproducible and exceedingly high transgenesis
efficiencies upon injection and germline transmission for diverse transgenes. Guided by community feedback
to expand on our first two landing sites, in Aim 1 we will generate next-generation landing sites for reporter and
enhancer testing applications in our validated loci and will establish previously challenging new Cre/lox tools.
However, our current landing sites on chromosomes 14 and 24 limit combinatorial transgene experiments and
strain health through inbreeding; additional landing sites with different properties (expression strength,
maternal contribution, etc.) on other chromosomes are critically needed akin to Drosophila and mice. In Aim 2,
we will streamline mapping of established, faithful transgenes using innovative DNA capture and long-read
sequencing to identify suitable additional safe-harbor sites and to generate additional landing site strains and
quasi-enhancer traps for diverse biomedical research applications. Our reagents and protocols will be openly
accessible through the Zebrafish International Resource Center (ZIRC), Addgene, and direct distribution.
Together, our work aims to advance zebrafish transgenesis applicable across NIH institute interests, greatly
reducing the required resources, animals, and time to establish transgenic zebrafish strains.

Public health relevance
PROJECT NARRATIVE The generation of transgenic animals is an essential technique for any model system. In zebrafish as major model for development and human disease, routine transgenesis techniques use random integration of transgenes into the genome, requiring time- and resource-intensive screening and validation of new transgenic zebrafish strains. Funding on our leading transgenesis expertise, we developed targeted, high-efficiency transgenesis into safe-harbor landing sites in zebrafish that we will expand into a sustainable community resource for next-generation transgenesis, as applicable for numerous biomedical research directions.